Rapid, Breath Volatile Metabolite-Based Diagnosis, Species Identification, and Antibiotic Resistance Profiling in Bacterial Pneumonia

Project Summary/Abstract:
A lack of diagnostics that rapidly and accurately identify bacterial pneumonia drives excessive empiric
antibiotic prescribing in patients with acute respiratory infections – 30-60% of these antibiotics are
unnecessary. Clinicians are under pressure to make rapid treatment decisions, usually without real-time
diagnostic information that reliably differentiates patients with bacterial pneumonia from other conditions
with similar clinical presentations. While time to effective treatment is a critical determinant of clinical
outcome, many patients with pneumonia receive inadequate empiric antibiotics due to rising rates of antibiotic
resistance in bacterial pneumonia pathogens. In contrast to bloodstream, gastrointestinal, or urinary tract
infections, the lung is a particularly challenging space to access without invasive diagnostic procedures. We
have established proof of concept in murine models that there are clear, bacterial species-specific breath
volatile metabolite signatures in pneumonia, and that microbial breath volatile metabolites have markedly
different responses to antibiotic exposure within a few hours in phenotypically susceptible vs. non-susceptible
organisms. In close collaboration with a team of engineering, biostatistical, antimicrobial resistance, and
regulatory experts, we will apply an advanced, portable, miniaturized gas chromatography-differential mobility
spectrometry (GC-DMS) diagnostic platform to the rapid, noninvasive, point-of care diagnosis of bacterial
pneumonia. We will derive breath volatile metabolite signatures that differentiate bacterial pneumonia from
other clinical syndromes with a similar clinical presentation, identify the underlying bacterial species directly
from metabolic fingerprints in the breath, and provide phenotypic information about antibiotic susceptibility,
harnessing early differential metabolic responses to effective vs. ineffective antibiotic therapy. This assay will
sharply reduce diagnostic delays in patients with pneumonia, both facilitating early administration of
appropriate antibiotics and curtailing unnecessary antibiotic use.

Public health relevance
Project Narrative: Pneumonia is a leading cause of morbidity and death, with no improvement in pneumonia-associated mortality rates since the 1950s. Because of rising antibiotic resistance in bacteria and significant limitations in the accuracy of diagnostic tests for pneumonia, many patients receive antibiotic treatment that is either ineffective against the bacteria causing their pneumonia or entirely unnecessary – while suspected pneumonia drives 49-60% of antibiotic prescribing in the United States, 30-60% of these prescriptions are ultimately unnecessary or inappropriate. We will further develop a rapid breath test for the diagnosis of bacterial pneumonia and early determination of whether the bacteria is susceptible to the antibiotic being used – this would allow patients with bacterial pneumonia to be identified earlier and more accurately than currently possible, improving clinical outcomes and reducing unnecessary antibiotic use.